Expansion of Immuno-CometChip Platform

Project Summary: The objective of this supplementation request is to further our recent advances in the development of the 96-well Immuno-CometChip assay results and build a prototype 384-well preformer giving the assay more utility and increasing commercial viability.